DIETARY FACTORS IN THE ETIOLOGY OF CANCER IN SHANGHAI

We are requesting continued support for an ongoing cohort study of 18,244 men, ages 45-64, living in a geographically defined area of metropolitan Shanghai, People's Republic of China. During the current funding period, we identified cohort members and collected detailed diet and medical histories and blood and urine samples on each. Questionnaires have been edited and computerized and blood and urine samples have been processed, aliquoted and stored at both -20 degrees C and -70 degrees C. Among the major goals of the study are to (1) determine the independent and interactive roles of hepatitis B virus and aflatoxin exposure in the etiology of hepatocellular carcinoma. Evidence of chronic hepatitis B virus infection is being determined by radioimmunoassay for the presence of hepatitis B surface antigen and evidence of aflatoxin exposure is being determined by urine measurements of aflatoxin metabolites and DNA adducts and of serum aflatoxin-albumin adducts and by individual dietary histories augmented with food surveys of aflatoxin contamination; (2) determine the independent and interactive roles of intake of salt (as estimated by urinary sodium/creatinine ratios), intake of nitrate and N-nitroso compounds (measured by urinary assays), vitamin C deficiency (determined by a serum absorbance spectrophotometry assay and by the detailed dietary history), and H. pylori infection (as measured by serum RIA) in the etiology of stomach cancer; and (3) determine the role of carotenoid/vitamin A deficiency and any interactive effect with cigarette smoking in the etiology of lung cancer. Follow-up of the cohort is proceeding as planned through cancer registration by the population-based Shanghai Cancer Registry, by routine ascertainment of death certificates, and by annual recontact of all cohort members. Preliminary analyses reveal strong associations between both urinary aflatoxin metabolites, DNA adducts and HBsAg positivity and liver cancer risk. A weak inverse association has been observed between serum levels Of beta-carotene and lung cancer risk. There is no evidence to date of a relationship between urinary sodium/creatinine ratios or serum vitamin C levels and stomach cancer risk.